Staff Investigators - Kaplan & Phillips

The UCSF Helen Diller Family Comprehensive Cancer Center is requesting funding for partial salary support for Staff Investigators who lead key research initiatives within the Center that are not reflected elsewhere within the programmatic structure. The five Staff Investigators (Coordinators) were chosen for their expertise and leadership qualities. Our Coordinators join the rest of the Center leadership in our quarterly Center Leadership retreats.